Paraneoplastic Disorders of the CNS: Autoantigen Profiling

DESCRIPTION (provided by applicant): The identification of immune responses against neuronal proteins in patients with cancer and neurologic disorders, known as paraneoplastic neurologic disorders (PNDs), has uncovered the existence of antigens shared by some cancers and the nervous system. As part of the immune response patients develop characteristic serum and cerebrospinal antibodies. Detection of these antibodies in a patient with neurologic disease of unknown etiology establishes the diagnosis of PND and focuses the search of the tumor to a few organs. This is important because, 1) in most patients the presence of a cancer is unknown at the time the PND develops, and 2) prompt diagnosis and treatment of the tumor is critical for improving the neurologic outcome. Of all patients suspected of having a PND, only 60% harbor antibodies to known target antigens. The hypothesis of this proposal is that antibody-associated PND are more frequent than believed. We postulate that the current techniques of antibody detection underestimate the true incidence of antibody-associated PND. Moreover, we postulate that some antibody-associated neurological syndromes may occur with or without cancer. To support our hypothesis we developed and validated a highly sensitive strategy for the rapid identification of antibodies in patients previously considered antibody-negative. This resulted in the isolation of 10 novel antibody associated disorders, targeting intracellular proteins and cell surface ion channels or receptors (AMPA, NMDA, GABAB receptors) with critical synaptic functions. While the intracellular antigens are important as surrogate diagnostic markers of PND and specific tumors, the cell surface antigens are notable for 4 reasons: 1) the associated disorders can occur with or without cancer and affect young individuals and children, 2) they are treatment-responsive, 3) the antibodies have direct effects on the target antigens, suggesting they are pathogenic, and 4) some antibodies define new syndromes. These novel antibody/antigen associations not only provide diagnostic tests but also direct the treatment approach. This proposal is an extension of this work and focuses on the comprehensive identification of autoantigens in four disorders: 1) rapidly progressive dementia with CSF inflammatory/autoimmune features, 2) opsoclonus-myoclonus-ataxia, 3) acute encephalitis with dyskinesias, and 4) encephalitis with refractory-relapsing seizures. The long-range goal is to develop autoantigen arrays to facilitate diagnosis and guide therapy. The two specific aims are: 1) To identify autoantigens of PND and similar syndromes using modified highly sensitive methods for the presence of antibodies to intracellular and neuronal cell surface antigens, and 2) To characterize the target synaptic antigens and determine the effects of patients' antibodies on the antigens and synapses in neuronal cultures.

Public health relevance
We have and propose to continue to identify new disorders of the nervous system that are due to the dysfunction of the patient's immunological system. This research has led to the development of blood tests to diagnose these disorders and the determination of appropriate treatments. Some of these disorders can be fatal if not diagnosed or properly treated and therefore, this work has resulted in improved outcomes for these patients.